Phospho-regulation as a driver of inhibitory synapse function

Phosphorylation has long been studied as a way to shape protein function after translation. In the brain, phosphorylation has emerged as one of the most efficient ways to transduce activity-dependent information to altered synaptic function. Extensive literature supports phosphorylation as an essential component of signal transduction at glutamatergic excitatory postsynapses within the CNS. Emerging evidence, however, demonstrates that GABAergic inhibitory postsynapses also undergo activity dependent plasticity. Based on limited candidate studies, a handful of GABAergic proteins have recently been shown to be phosphorylated at inhibitory synapses. While this supports phosphorylation as a likely mechanism to modulate inhibitory synapses, an in-depth analysis of how phosphorylation is coupled to inhibitory synapses function has not been attempted. Moreover, it is still unclear as to which kinases are present and therefore act at inhibitory synapses. Thus, the inhibitory synaptic phospho-proteome is currently a “black box”, which is a significant barrier to understanding how activity modifies inhibition important for shaping experience-dependent brain function. Here, I propose to use a cutting edge in vivo chemico-genetic approach to identify phosphorylated proteins at inhibitory synapses in combination with CRISPR-depletion, optogenetics, electrophysiology and imaging to understand how kinases orchestrate the complex yet fundamental workings of the inhibitory synapse.

Public health relevance
Excitation and inhibition must be balanced in neurons to control synaptic output for proper information processing; this is achieved by influencing firing rates and connectivity between local circuitry and long-range neural networks within the brain. Excitatory synapses and their plasticity have long been studied, however the mechanisms underlying inhibitory synapse function are still largely unexplored. This proposal investigates phosphorylation as a key signaling mechanism to control inhibitory synapse function and organization both at baseline and with neuronal activity.